Optogenetic silencing to achieve antiarrhythmic effect of renal denervation in chronic heart failure

Project Summary
Ventricular arrhythmia is the leading cause of death for chronic heart failure (CHF) patients. Although the
therapeutic potential of renal denervation (RDN) for ventricular arrhythmias has been reported extensively, RDN-
induced adverse complications severely limit its use in the clinic. Our recent study revealed that macrophage
expansion and neuroinflammation in the stellate ganglion (SG) contribute to CHF-increased cell excitability of
cardiac sympathetic postganglionic (CSP) neurons, which subsequently promotes cardiac sympathetic
overactivation and ventricular arrhythmogenesis in CHF rats. Granulocyte-macrophage colony-stimulating factor
(GM-CSF) is a crucial mediator in macrophage activation. Our pilot data showed that RDN attenuates cardiac
sympathetic overactivation and ventricular arrhythmias, which are accompanied by the marked reduction of GM-
CSF level and macrophage activation in SGs in CHF rats. However, it remains unclear if the antiarrhythmic effect
of RDN is achieved via attenuating GM-CSF-mediated inflammatory pathways in SGs in CHF. Following the
discovery of the antiarrhythmic mechanisms of RDN, this proposal aims to develop a novel clinical intervention
to achieve the therapeutic role of RDN and avoid its limitations. Since sympathetic innervation of the kidney
originates primarily from neurons in the aorticorenal ganglion (ARG), targeting ARG neurons could be a logical
therapeutic strategy for achieving the antiarrhythmic role of RDN. Considering the advantages of optogenetics,
including rapid, specific control of neuronal activities by light-sensitive opsins, adeno-associated-virus-
Archaerhodopsin (ArchT, an inhibitory light-sensitive opsin) gene will be transfected into ARG neurons in CHF
rats. Specificity of neuronal expression of ArchT in ARG neurons will be achieved by linking a neuron-specific
promoter to the ArchT gene. Continual optogenetic silencing in ARG neurons will be achieved by illuminating a
LED probe that is controlled and powered wirelessly in freely moving animals. We hypothesize that optogenetic
inhibition of ARG neurons would reduce CHF-elevated GM-CSF level in SGs, which subsequently alleviates
macrophage activation and neuroinflammation in SGs, thereby attenuating CSP neuronal excitability, cardiac
sympathetic overactivation, and ventricular arrhythmogenesis in CHF. Using multi-faceted technical approaches
ranging from whole-animals to cellular-molecular levels, we will design in vivo and in vitro studies to assess these
questions. Specific Aim 1, we will test if GM-CSF signaling axis contributes to macrophage activation and
neuroinflammation in SGs from CHF animals. Specific Aim 2, we will address if GM-CSF signaling pathway
contributes to CHF-increased cell excitability of CSP neurons, cardiac sympathetic overactivation, and
ventricular arrhythmogenesis. Specific Aim 3, we will determine if optogenetic silencing in ARGs can achieve
the antiarrhythmic effect of RDN by attenuating GM-CSF-induced macrophage activation and neuroinflammation
in SGs in CHF. These studies will open a new avenue in therapeutics against lethal ventricular arrhythmia and
provide a novel clinical intervention to reduce mortality and improve outcomes and quality of life in CHF patients.

Public health relevance
Project Narrative Cardiac sympathetic overexcitation-related fatal arrhythmia is the most common cause of death in patients with chronic heart failure (CHF). However, concerns about the safety and tolerability of current therapies, such as surgical procedures and medications, are emerging as a limitation to their prescriptions in the clinic. This project will introduce a novel therapeutic strategy using an optogenetic technique to restore CHF-induced cardiac sympathetic overexcitation, and observe whether this strategy reduces cardiac arrhythmia and mortality in animals with CHF, which will provide a novel clinical intervention to avoid the limitation of current therapies and improve prognosis and quality of life in patients with CHF.